Administrative Core

Project Summary. The Administrative Core forms the nucleus of the COBRE Phase III Center for Neuroplasticity
at the University of Puerto Rico. It supports the four-fold objectives of this COBRE Center: 1) Recruit and foster
development of early career investigators working on projects with broad biomedical relevance to neuroscience
and neuroplasticity, 2) Upgrade, maintain, and promote a state-of-the-art instrumentation core that combines
imaging and electrophysiological approaches, 3) Implement a long-term business plan that will sustain the UPR-
CCfN, the Neuroimaging and Electrophysiology Facility (NIEF) core, and programmatic activities that promote
multidisciplinary collaborations at the basic and translational levels, 4) Sustain an island-wide globally recognized
COBRE Center for Neuroplasticity with translational and therapeutic applications to neurodegenerative and
neurodevelopmental disorders. The Administrative Core incorporates all programmatic facets of this initiative,
including Faculty Career Development Activities (Laboratory Management, Grant Writing, Manuscript
Preparation) and Neuroscience Research Infrastructure Enhancement programs (Seminar Series,
Neuroscientist-in-Residence, Annual Puerto Rico Neuroscience Conference, Outreach Activities, and Academic
Partnerships). The Administrative Core is composed of a team of individuals with proven track records and
experience in the operation and management of large multi-faceted research and training programs. Oversight
is the responsibility of the Administrative Core Director, Dr. Mark Miller. Miller serves as liaison between the
program and its Evaluation Module and he coordinates communication with NIGMS officials. The Administrative
Support Office will continue to be staffed by a highly experienced and dedicated team, including Ms. Bethzaida
Birriel, Grants Administrator and Ms. Brenda Caban, Accountant. All fiscal matters will be managed at the UPR
Molecular Sciences Resource Center (MSRC) and at the Institute of Neurobiology, two freestanding units of the
University of Puerto Rico. Core personnel will handle most aspects of the post-award administration of funds,
including hiring of technicians, postdocs, and students. Finally, the Administrative Core will coordinate all
program appraisal and assessment, including the participation of an independent external evaluation team from
Cooperativa de Servicios de Evaluación e Investigación (CoopSEI). The Administrative Core team will organize
the Annual COBRE Retreat and Assessment Activity that will enable all stakeholders to meet, exchange ideas,
report progress, and plan future strategies. This meeting will serve as the principal forum for developing and
disseminating data required for formative and summative evaluation of all COBRE Center research objectives
and programmatic initiatives.

Public health relevance
Project Narrative – Administrative Core The Administrative Core of the University of Puerto Rico COBRE Center for Neuroplasticity Phase 3 will support all scientific, faculty mentoring, and institutional development objectives of this program. Executive and fiscal program management will be carried out by a team of personnel with a proven track record in the operation and management of large multi-faceted research programs. The Administrative core will serve as the liaison with the program’s evaluation module and with the External and Internal Advisory Committees.